Administrative Core

ABSTRACT - ADMINISTRATIVE CORE
The Administrative Core will provide the day-to-day administrative and logistical support, coordination,
documentation, tracking, resource allocation, and integration of facilities, faculty, core resources, and research
projects within the Center for Accelerating Excellence in Translational Science (AXIS). Our overall goal is to
provide CDU investigators, staff, faculty, and collaborators the support to continue to be productive, submit
competitive grant submissions, and publish their work in high-impact journals. Our team will communicate
between the faculty and the core leaders to provide effective and career-enhancing seminars, trainings,
workshops, conferences, and outreach events. The core will work with institutional offices to facilitate and
allocate resources and activities to build CDU’s research capabilities and enhance its investigators from all
levels. To ensure the center and its services maximize their capabilities, the core will evaluate the cores and
communicate their progress with institutional leadership, the RCMI Coordinating Center, and its advisory
committee (AC), which includes individuals from community and scientific backgrounds. Our advisory committee
will work to identify future directions for AXIS. In the renewal, we will continue to align university infrastructure
resources that work to eliminate health disparities, specifically through three areas of focus that disproportionally
affect the surrounding Los Angeles Service Planning Area 6: Cancer, Cardiometabolic disease, and HIV/AIDS.
We continue to align our goals with the university's commitment to cultivating diverse health professional leaders
dedicated to social justice and health equity for underserved populations through outstanding education,
research, clinical service, and community engagement. The university has continuously supported its
researchers and works to expand, enhance, and integrate the research mission. The administrative core will be
a leader to ensure that administrative leadership executes the alignment and research allocation. We will
continue to enhance resources from other NIH-funded research centers, programs, and partnering institutions.